Discovery of streptococcal natural products with activity against the endodontic pathogen Enterococcus faecalis

Abstract/Summary
Bacteria in the oral cavity contribute to human health and disease. Streptococcus mutans is commonly found
in the oral microbiome and is recognized as a leading cause of caries (cavities). Some infections in the oral
cavity can also occur after endodontic treatments such as root canals. Millions of patients undergo root canal
procedures each year, and root canal failure rates can be as high as ~20%. A leading cause of infected root
canals is the Gram-positive bacterium Enterococcus faecalis, which is found at low abundance in the
gastrointestinal tracts (GIT) of humans, animals, and insects. E. faecalis can also be an opportunistic
pathogen causing infections on implanted devices and in body sites such as the urinary tract, bloodstream, and
wounds. Despite its prevalence in root canal infections, E. faecalis is not typically considered part of the core
oral microbiome. Our preliminary data shows that natural products (such as non-ribosomal
peptides/polyketides) synthesized by S. mutans can kill E. faecalis and other Gram-positive bacteria. Through
this proposal, we will identify natural products with anti-bacterial and anti-biofilm activity produced by additional
strains of S. mutans using a combination of targeted gene deletions, bacterial co-culture assays, and mass
spectrometry. Additionally, we will test the hypothesis that S. mutans biofilms producing these natural products
can exclude E. faecalis from invading pre-formed biofilms and can shape biofilm dynamics in conditions
relevant to the oral cavity. This work will serve as the foundation for a future R01 to NIDCR to test models of
colonization resistance and dysbiosis that may govern E. faecalis dynamics in the oral cavity, and to determine
how streptococcal natural products shape the ecology of the oral microbiome.

Public health relevance
Project Narrative Root canal failure can be caused by the Gram-positive bacterium Enterococcus faecalis, which is not typically part of the normal oral microbiome but is a low abundance commensal in the gastrointestinal tract and can cause infections at multiple body sites. We demonstrated that antibiotic-like natural products produced by the oral bacterium Streptococcus mutans, which causes caries (cavities), can kill E. faecalis and other Gram- positive pathogens. Our work will identify additional anti-bacterial streptococcal natural products and measure their anti-biofilm activity against E. faecalis, which will enable us to better predict and treat endodontic infections.